Enrichment Program

PROJECT SUMMARY/ABSTRACT
The University of Chicago (UChicago) Digestive Diseases Research Core Center (DDRCC) for
Interdisciplinary Study of Inflammatory Intestinal Disorders (C-IID) Enrichment Program promotes knowledge,
the exchange of ideas, training, and education in a culture of multidisciplinary interaction, collaboration, and
synergy. It serves as a forum to present and discuss research in progress, provides opportunity for
investigators with Pilot and Feasibility Studies to present their findings, informs its membership of new trends,
discoveries, programs, grant opportunities, and development in the C-IID through its conferences, semiannual
newsletters and email communications. The Program supports training and educational opportunities inside
and outside of the University through its core specific educational offerings, mini-retreat program, and annual
C-IID retreats, which have been widely subscribed and impactful. The program has been highly successful in
achieving these goals but will soon implement several new initiatives under new directorship to improve and
expand upon existing platforms.